Development and Testing a Field-based Hazard/Near-Miss Sharing System for Commercial Fishing Vessels

Project Summary/Abstract This project will design, build and roll out a field-based near miss and lessons learned sharing system that can achieve broad adoption in the commercial fishing industry. Comparing to existing reporting systems which focus on serious reportable marine casualties, this new system aims at collecting hazard and near-miss data across the industry. The data will be submitted anonymously to an independent, non-regulatory organization for further analyses and dissemination. The project results will focus on how to effectively collect the data, analyze the data, and communicate key lessons learned and summary information directly to commercial fishing vessel captains/crews to improve their safety awareness. The project objective is to help address critical information gaps about commercial fishing safety and create better informed safety programs and interventions for captains/crews across the industry. The project team will research existing near-miss/hazard reporting systems and perform needs assessment by meeting with potential users in the commercial fishing industry. Then, an incident/near-miss/hazard taxonomy will be developed to structure data collection. The project team will develop a data collection process and identify the requirements to administer data collection, quality assurance, quality control, and dissemination. The team will develop a mobile application and a web application, which the team will develop and test following a standard software development lifecycle. Once completed, the sharing system will be hosted by an independent, non-regulatory organization and made available on public mobile app stores (for the mobile application) for access by commercial fishermen. A project analysis will evaluate roll-out success, adoption, usage experience, and value of usage. The project team will test the value of the data collection over time, through a set of output and outcome measures. Specific project outputs will be: • The incident/near-miss/hazard taxonomy that will provide the foundation on which fishermen will report and categorize shared submissions • A mobile application for submitting incidents, near-misses, and hazards (lessons learned) • A web application for the analysis and visualization of submitted records • Collected and analyzed anonymous data for safety training, awareness, and research efforts

Public health relevance
PROJECT NARRATIVE The project will develop and test a field-based near-miss and lessons learned sharing system for commercial fishermen, enabling simple collection and sharing of near-misses (precursor events), observed hazards, and lessons learned among commercial fishermen on a voluntary, non- attributional basis. The system will address critical information gaps about commercial fishing safety, resulting in improved safety communications, greater hazard identification, and more accurate perceptions and management of risk that contribute to higher levels of safety in commercial fishing. The project will also create key lessons learned and summary information to help commercial fishing vessel captains/crews improve their safety awareness.